VA Boston Healthcare System Summer Research Program: Imaging, Computers, and AI in Medicine

Objectives: It is evident to VA researchers that we must continue to enhance workforce diversity in order
to remain in lockstep with the ever-increasing diversity of the Veteran Population that we serve. Broadly
speaking, American biomedical research has neglected diversity on many levels, but recognition of this
fact is causing rapid course corrections. Beyond basic ethical issues, a lack of diversity also hinders
scientific progress. Evidence has been accumulating that programs that enhance diversity are beneficial
to research quality and effectiveness. Research teams with diverse perspectives offer multiple viewpoints
and experiences that would not be represented otherwise. Diverse voices augment innovation, creativity,
critical thought, scientific rigor, and identification of scientific biases. Building on lessons-learned and trails-
blazed during our own two-year experience with a Pilot Summer Research Program (SRP) Award, we now
seek to establish and resource a longer term, small-format, follow-on SRP designed to promote diversity
of the VA scientific workforce. We seek to accomplish this by systematically attracting undergraduate and
pre-master’s students from under-represented populations into VA biomedical research.
Our goals for this grant are to create, for eligible US Citizens, a 9 to 10-week undergraduate SRP for
individuals from populations currently identified as underrepresented in VA research. Eligible individuals
will be drawn from students enrolled in full / part time degree / certificate programs at accredited colleges,
universities, community colleges, or schools of allied health professions. We aim to establish a longitudinal
SRP curriculum encompassing didactic activities, one-on-one faculty instruction, exposure to clinical
medicine at the VA, and immersion in an approved research project that may involve human subjects.
There will be structured complementary exposure to topics such as the design and performance of
translational clinical studies, data management, and biomedical engineering. Didactic lectures and
seminars will be hybrid thus enabling students to tap into both local hands-on instruction as well as remote
teaching occurring at other partner VA SRP sites, a model used successfully in our Pilot SRP. In addition,
the program will enable students to participate in a clinical-translational research project with a VA-based
primary mentor. This work is expected to culminate in an abstract submission to a national meeting, the
Annual Biomedical Research Conference for Minoritized Scientists (ABRCMS), held in the Fall. Attendance
and presentation of work at ABRCMS has been lauded as a major highlight by all of our students to date.
This is another unique tradition made possible by the VA Pilot SRP that we would love to see continued in
a Boston over the long term.

Public health relevance
Low-cost high-power computing is driving an explosion in machine learning and pattern recognition in healthcare. It is not an overstatement to say that artificial intelligence (AI) is the future of medicine both in and out of VA. Boston is fortunate to have a group of multidisciplinary investigators interested in translational imaging and AI. Areas of interest include diagnostic and interventional endoscopy, endosurgery, neuroimaging, optical coherence tomography, radiology, and histopathology. AI models are only as good as the quality and relevance of training data, highlighting the need to represent the unique, increasing diversity of our Veteran population. To achieve this goal, VA researchers must represent an equally diverse pool. We seek to build upon our Pilot experience with a 5-year summer program. We seek to recruit undergraduates from groups underrepresented in VA research with the goal of retention within the VA research workforce over the long term.